Huntsman Cancer Institute PathMaker Programs for Cancer Research

The overarching goal of this R25 application is to enhance the diversity of the pool of individuals from
underrepresented groups interested in pursuing careers in biomedical and cancer-related research by
providing research experiences for high school and undergraduate students, research and curriculum
development experiences for middle and high school science teachers, and outreach to middle school
students, their families, and their communities. The Huntsman Cancer Institute PathMaker Programs for
Cancer Research will bring exceptional cancer research training pipeline programs to Utah and the Mountain
West to support the National Cancer Institute’s R25 program goal of increasing diversity of the biomedical,
behavioral, and clinical research workforce. The proposed program, building on successful P30 CURE and
FRTEP Supplements, will comprise three interrelated and complementary components: PathMaker Scholars,
PathMaker Bridge, and PathMaker Connect. PathMaker Scholars is a mentored cancer research experience
for high school and undergraduate students; PathMaker Bridge provides mentored cancer research
experiences and guided curriculum development for middle and high school science teachers, providing a
bridge to their students; with PathMaker Connect we will connect HCI and the two previously-mentioned
groups to a specific community through an innovative outreach event. While applicants from all groups
underrepresented in biomedical research will be encouraged and welcomed, recruiting efforts will focus on
students who belong to one of three minority groups significant to Utah and Salt Lake City: Hispanic/Latino,
American Indian or Alaska Native, or Native Hawaiian or Pacific Islander. Hispanic/Latinos comprise Utah’s
largest minority population, with 14% of the overall population and nearly 18% of the population under 18 years
of age. Also, Utah is home to eight American Indian tribes or nations, and a surprisingly large Pacific Islander
population including one-fourth of all Tongan Americans. These groups are massively underrepresented in
biomedical research, and they face significant cancer-related health disparities. This project will be led by a
team comprising a physician scientist and a basic scientist, who have relevant experience in programs to
increase diversity in biomedical research careers, career mentoring, and biomedical research career training.
Student research experiences will be enhanced by a rich professional preparation and community-building
program. Additionally, PathMaker Bridge will partner with the internationally-recognized University of Utah
Genetic Science Learning Center (GSLC) to provide an exceptional professional development program to
guide teacher participants in using their research experiences to create novel curricular materials, with the
potential for world-wide dissemination on the GSLC website. A professional evaluator will provide formative
and summative evaluation to ensure the program achieves its maximum potential.

Public health relevance
NARRATIVE This project establishes cancer research programs for high school and undergraduate students, as well as for middle and high school science teachers, to increase the pipeline of students currently underrepresented in the biomedical sciences who are interested in biomedical research careers. The long-term goal of this project is increase diversity in cancer-related and other biomedical research careers with the ultimate goal of eliminating health inequities.